RANDOMIZED DOUBLE-BLIND COMPARISON OF ATRACURIUM AND VECURONIUM INFUSIONS

The objective of the study is to determine if either atracurium or vecuronium is better for muscle relaxation in critically ill children requiring mechanical ventilation. The end points of the study are the number of dose adjustments for each agent during the course of therapy and the time to return of normal neuromuscular transmission after the agents are discontinued. Ten patients have been enrolled into the study to date. Since the study is blinded, no results are available. Although neuromuscular blocking agents have been used as adjuncts in critically ill patients on mechanical ventilation for the past thirty years, there has never been a controlled trial evaluating their use. This is the first scientific trial evaluating the dosing requirements and recovery times of these agents in critically ill patients. 11 of 20 patients have been enrolled to date. The remaining 9 patients should be enrolled by the winter of 1994.